Insight into the mechanism of action of the SSB interactome

ABSTRACT OF THE PARENT GRANT
The single-stranded DNA binding protein (SSB) is the founding member of the nineteen-partner SSB interactome. There is
a fundamental gap in understanding the mechanism of action of the interactome, the first prokaryotic family of
oligosaccharide/oligonucleotide binding fold (OB-fold) genome guardians identified. The continued existence of this gap
represents an important problem because, until it is filled, a complete and clear understanding of genome stability will be
lacking. This understanding is crucial as defects in OB-fold genome guardian family members have disastrous consequences
for genome stability. In higher organisms, mutations in the three OB-folds of BRCA2 ultimately result in cancer, and the
proposed studies are therefore directly relevant to human disease. Consequently, the long-term goal is to understand the
molecular mechanism of the SSB interactome. The main objective of this proposal is to understand how SSB interacts with,
and regulates, several partner proteins and itself, to maintain genome integrity. The central hypothesis is that two regions
of SSB known as the linker and the OB-fold, (present in both SSB and interactome partners), are the key elements to all
aspects of protein function. The rationale for the proposed research is that once it is known how SSB physically and
functionally interacts with both itself and its partners, a clearer understanding of the events required to maintain genome
integrity, mediated by this OB-fold family of genome guardians, will be obtained. The central hypothesis will be tested by
pursuing two specific aims: 1) determine the role of the linker/OB-fold network in SSB function; and 2) determine the
mechanism of action of the SSB interactome. Under the first aim, a combination of in vivo and in vitro binding assays,
HDX-MS, protein crystallography, cryo-EM, and single-molecule biochemistry will be used to determine whether the
linker/OB-fold interface is the primary means of SSB-partner binding. Under the second aim, enzyme kinetics, genetics,
real-time super-resolution microscopy, and single-molecule biochemistry will be used to understand how the linker/OB-
fold network mediates SSB interactome function in the dynamic reactions of DNA replication, recombination, and repair.
The proposed research is innovative because of the combinatorial strategy taken, the novel single-molecule approaches
used, and the care that we will take in elucidating SSB interactome function using full-length proteins. The proposed
research is significant because it will allow, for the first time, the development of a clear picture of SSB interactome function
in DNA metabolism and the maintenance of genome integrity.

Public health relevance
PUBLIC HEALTH RELEVANCE Understanding the mechanism of action of the SSB interactome is important to public health as the interactome is an OB-fold family of genome guardians and defects in these families in higher organisms lead to the accumulation of mutations leading to cancer. The proposed research is relevant to the part of NIH's mission that pertains to fostering fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health.